SEROTONIN 1A RECEPTOR FUNCTION IN PATIENTS WITH EATING DISORDERS AND CONTROLS

This study will investigate the importance of serotonin-1A receptor function in patients with eating disorders and in healthy controls.